Leveraging Hispanic/Latino diversity to map and characterize cardiovascular disease loci

SUMMARY
Cardiovascular disease (CVD) is a leading cause of morbidity and mortality among US Hispanic or Latino (H/L)
populations. H/Ls are a relatively young population and experience heightened disparities in risk for most CVD
risk factors, including obesity, type 2 diabetes (T2D), dyslipidemia, and hypertension; therefore, their absolute
CVD burden is expected to increase. The major public health and clinical challenge imposed by CVD has
motivated large efforts to understand underlying biologic mechanisms–a critical barrier to treatment, risk
stratification, and ultimately, disease prevention. Thousands of genetic loci for coronary heart disease (CHD)
and CVD risk factors have been mapped influencing risk of CHD via perturbations of lipid metabolism, blood
pressure regulation, inflammation, and platelet function, as well as through mechanisms that remain unknown.
Yet, genome-wide association studies (GWAS) for CHD and stroke in H/L populations have been scarce.
Indeed, despite previous work on the genetics of CVD risk factors in H/L (several by our group), no stand-
alone GWAS for CHD and stroke in H/L has been published. Thus, for CHD, stroke, and CVD risk factors, the
knowledge gap between genomics, public health, and medicine could be improved by enriching the genomic
translational pipeline, which includes discovering new loci for CVD related traits and their underlying causal
variants; elucidating the biological and/or pathophysiological mechanisms; and establishing evidence for
clinical utility and/or impact on health outcomes. We propose to leverage extant data on H/L individuals from
large epidemiologic and clinical biobank studies and to generate new eQTL data to discover and characterize
the genetic architecture of CVD risk and events in H/L populations. Our specific aims are to (1) discover and
characterize the genetic architecture of CVD related traits in Hispanic/Latinos through meta-analysis of studies
ascertaining more than 159,622 H/L participants in total; (2) derive the first ever H/L-specific eQTL map to
build H/L-relevant gene expression prediction models and apply these models to our study samples with
genotyping data (discovery sample less the participants with measured RNA: n~146,822) and conduct
transcriptome-wide association studies (TWAS) analyses in each individual study followed by meta-analysis
for each trait of interest; and (3) perform colocalization and to sample Mendelian Randomization (MR) analyses
to identify causal genes amongst H/L CVD risk loci, and use electronic health record (EHR)-linked biobanks
to characterize the broader clinical impact of loci via phenome wide association studies (PheWAS) for H/L
CVD risk loci. Our study is high impact as the burden of CVD is rapidly growing in Hispanic/Latino populations
and demographic trends suggest that the H/L population will constitute ~35% of the US population by 2050.
Our research will ensure diverse populations are not the last to benefit from the new era of precision medicine
at the same time it develops expedited strategies for translating genomics to function and clinical utility.

Public health relevance
NARRATIVE Large genetic studies in minority populations are rare, yet are imperative for understanding cardiovascular disease (CVD) risk and events. This study will combine epidemiological and clinical data coupled with genetic and transcriptomic data t o study CVD risk and events in Hispanic populations living in the US and in Latin America.